Autophagy and Megamitochondria in Cardiac Aging and Heart Failure

Project summary
As average life expectancy continues to rise in the developed world, age associated pathologies are
increasingly prevalent. Aging is a major risk factor for cardiovascular diseases and the hallmarks of cardiac
aging include loss of myocytes, fibrosis and hypertrophy, all of which contribute to increased incidence of
cardiac disease. At the molecular level, cellular aging is characterized by increased reactive oxygen species
(ROS) production, mitochondrial dysfunction and accumulation of damaged proteins and organelles. Cardiac
myocytes rely upon autophagy, a lysosome-mediated degradation pathway, to remove toxic protein
aggregates and damaged organelles from the cellular milieu. Increasing lines of evidence point to an age-
associated decrease in myocyte autophagy, with predictably negative consequences for cardiac function and
health. However, it is still unclear why autophagy declines with age and whether specific proteins or pathways
involved in regulating autophagy are altered with age. Mitochondrial dysfunction is also a key hallmark of aging
and has been linked to a number of age-related pathologies, including heart failure. In addition, enlarged or
megamitochondria are often present in aged tissues, but their potential contribution to the aging process and
disease development remain unknown. We have confirmed that autophagic activity is reduced in aged mouse
hearts which correlates with accumulation of ubiquitinated mitochondria. Our preliminary data also suggest that
the decrease in autophagic activity in the aged heart is due to altered expression of Atg9b, a key regulator of
autophagosome formation and elongation. We also found that the aged mouse heart contains a substantial
number of enlarged mitochondria. Why these megamitochondria form with age in the heart and whether they
contribute to the aging process are currently unknown. In this proposal, we will examine the hypothesis that a
decline in autophagosome formation and mitochondrial clearance in the aging heart leads to increased fusion
between dysfunctional and healthy mitochondria in an attempt to dilute damaged components. Over time,
these megamitochondria accumulate increased levels of damage. They become less functional and generate
increased ROS, which directly contribute to the cardiac aging process. This hypothesis will be tested with two
specific aims. Specific aim 1 will dissect the mechanism underlying the age-associated decline in autophagy.
Specific aim 2 will characterize the interplay between mitochondrial morphology and autophagy during aging.
We will also investigate if restoring Atg9b will enhance baseline autophagy in the aged hearts and whether
reduced mitochondrial ROS production will prevent or delay the age associated decline in autophagy and
abrogate formation of harmful megamitochondria. Overall, these studies will further our understanding of the
molecular mechanism underlying the aging process and help identify interventions to preserve mitochondrial
homeostasis and prevent development of disease.

Public health relevance
Project Narrative Mitochondria are important in providing energy for the contracting myocyte, but dysfunctional mitochondria can be harmful to the cell and needs to be eliminated by autophagosomes. This project will provide important new insights into the relationship between reduced autophagy and accumulation of defective mitochondria in the cardiac aging process.